Dietary sugar-regulated recombinant protein production in the gut

Probiotic bacteria offer great potential for use as therapeutic delivery vehicles due to their health-promoting
phenotypes, a long history of safe consumption, and the ability to survive passage through the mammalian
gastrointestinal tract. To express recombinant proteins, genes can be under the control of a constitutive promoter
on a plasmid. However, especially for proteins that are less tolerated, this places a metabolic burden on the cell
which hampers cell yield. One solution is controlled gene expression, in gram-positive probiotics accomplished
by two-component regulatory systems. However, these systems require an inducer peptide to induce gene
expression, which complicates the application in the gut ecosystem due to unpredictable pharmacokinetics of
the induction peptide during gastrointestinal transit. Moreover, from a safety perspective, plasmids harboring
genes conferring antibiotic resistance should be avoided. Thus, there is a critical need to develop technological
innovations with an inducer for plasmid-independent recombinant protein production that are independent of
induction peptides and antibiotic markers. Our long-term goal is to develop the probiotic human gut symbiont
Limosilactobacillus reuteri (Lr) as a therapeutic delivery vehicle for use in humans. Our group has pioneered the
approach of exploiting prophage-mediated lysis to release and deliver recombinant proteins, which has proven
functional in multiple preclinical models. The overall objective of this application is to develop the innovative
concept of plasmid-independent and carbohydrate-regulated production of recombinant proteins. Our central
hypothesis is that carbohydrate-regulated promoters fused to recombinant interleukin-22 (IL-22) will reduce liver
triglycerides in a diet-dependent manner. Our hypothesis has been formulated based on our preliminary data,
demonstrating the identification of tightly controlled sugar-inducible promoters. Also, published work from our
laboratory demonstrated that Lr engineered to release IL-22 ameliorates liver triglycerides, which means the
chosen preclinical model is a viable approach to test our hypothesis. The rationale for the proposed research is
that its successful completion will create exciting opportunities to expand the repertoire of dietary sugars and
their combinations in the application of tailored gene expression in the gut, which can be expanded to other
microbes and disease models. We plan to accomplish the overall objective by addressing the following specific
aims: (1) determine the therapeutic efficacy of dietary sugar-regulated recombinant protein production; (2)
determine the therapeutic efficacy following in vitro priming of recombinant protein production. The expected
outcomes are to have established that dietary sugars can function as an inducing agent for therapeutic
production when relying on in vivo or in vitro carbohydrate metabolism. Thus, a positive impact is expected as
our work will create previously unexplored opportunities to control (recombinant) protein production in the gut
with uses in basic biology, industry, and medicine.

Public health relevance
PROJECT NARRATIVE Our proposal is relevant to human health as we aim to develop a system in which simple sugars can be used to control therapeutic release in the gut ecosystem, which is expected to have a significant impact on the development of next-gen microbial therapeutics.